Role of sex and protein degradation in the circadian clock

Project Summary/Abstract
Circadian clocks influence nearly all aspects of mammalian life, aligning our internal
physiological process to optimal times of day. Understanding the molecular circuitry keeping
circadian time provides insight into how the clock drives overt rhythms and what to fix when the
circadian system is disrupted (i.e. during shift work). Circadian time coded in the rhythmic
regulation of “clock gene” expression in a negative feedback loop system. Critical to this timing
system is the circadian degradation of rhythmically abundant clock proteins, however, these
mechanisms have remained elusive. We have begun elucidating these mechanisms by
developing a novel functional screening approach designed to identify which E3 ubiquitin
ligases degrade which clock proteins.
The first screen hit we have recovered, Siah2, has revealed remarkable and unexpected
new insights into both clock function by uncovering the unexpected existence of female-specific
circadian mechanisms that control metabolism specifically in females. Unfortunately, the vast
majority of circadian data available are from male mice; thus, we have broadly started to
compare how the circadian system differs between males and females, and across the 4-day
estrus cycle (a huge potential but unstudied influence), in mice. Our studies in the liver so far
have revealed substantial sex-differences in the landscape of genes regulated across the day
between the sexes, and across the estrus-cycle. Furthermore, we have discovered that Siah2
also appears to regulate the circadian clock in several tissues an estrus-cycle dependent
manner (i.e., only on the day(s) prior ovulation), providing strong evidence that circadian clock
systems have highly sex-specific roles. Therefore, our goals for the next 5 years are to continue
filling in the gaps that exist in female circadian biology by further identifying the
differences/similarities between the sexes, leverage Siah2 as a tool to understand what these
mechanisms do, and why they are different. Understanding sex-differences in circadian clock
functions will be critical as the field develops circadian-based therapeutics.

Public health relevance
Project Narrative: Circadian clocks impact nearly every aspect of our health, and their chronic disruption by working on a rotating shift schedule can cause a variety of diseases, including obesity. New findings indicate that the mechanisms involved are highly sex-specific and contribute broadly to the overt biological differences between males and females. The experiments proposed in our application seek to identify these novel circadian clock mechanisms.